Structure, function, and dynamics of viral RNAs and RNA-containing complexes

PROJECT SUMMARY
Eukaryotic cells use diverse mechanisms to regulate translation, many of which depend on
structured RNA elements that interact directly with the protein synthesis machinery. This
ubiquitous and powerful strategy for regulating gene expression is also adopted by viral RNAs,
which must use the same biological machinery as cellular RNAs. Despite their importance, the
detailed mechanisms that underlie both cellular and viral RNA structure-dependent translational
control are poorly understood. To address this gap, we propose to build on our previous
discoveries of internal ribosome entry site (IRES) RNA function by studying two different but
related classes of viral RNAs that interface directly with the cellular translation machinery. The
first comprises a diverse class of viral RNAs called tRNA-like structures (TLSs) that mimic tRNAs
in mysterious ways and use this to bind a variety of cellular proteins; in so doing they enhance
translation by unknown means. As new putative tRNA mimics are being discovered, this work
promises insight of broad applicability. The second are termination upstream ribosome binding
sites (TURBS) RNAs, which exist at the interface between two open reading frames where they
drive ribosome reinitiation using unknown RNA structure. Evidence suggests that RNA sequence
and structure can play an important role in ribosome reinitiation, thus studies of these viral TURBS
promise to reveal foundational principles of this process. For these studies, we propose a
‘structure-forward’ strategy that exploits our substantial expertise in three-dimensional RNA
structure determination, coupled with biochemistry to link structure with function and develop
detailed new mechanistic models. In addition, we will use our structural discoveries to guide novel
bioinformatics searches aimed at finding new versions of these structured elements in both
cellular and viral RNAs. We anticipate that our work will inspire new questions about the nature,
diversity, distribution, and power of RNA structure-dependent control of translation, suggest new
systems to study, and help further understand broad underlying principles.

Public health relevance
PROJECT NARRATIVE Structured RNA elements are critical for regulating eukaryotic gene expression by diverse mechanisms, including at the level of translation. We are studying several examples of structured viral RNA elements that interact directly with the cell’s protein synthesis machinery and alter its function. Our goal is to uncover fundamental rules governing control of translation by RNA structure.